Uncovering the heterogenous role of senescence in prostate immune suppression and tumorigenesis

PROJECT SUMMARY
Prostate cancer is the second-leading cause of cancer-related death in American men. While most prostate
cancers are hormone sensitive and respond well to hormone therapy, a subset of patients will relapse with
lethal castration-resistant prostate cancer. It is still unclear why some prostate tumors remain indolent yet
others rapidly progress and relapse on therapy. As such there is an urgent need for new biomarkers of disease
progression and novel therapeutic targets and strategies for treatment-refractory prostate cancer. We and
others have identified markers of cellular senescence, a stress-induced program driven by oncogenic insult, in
prostate cancers from genetically engineered mouse models (GEMMs) and human patients. As senescence
leads to durable cell cycle arrest and induction of a senescence-associated secretory phenotype (SASP) that
can activate immune clearance of senescent cells, it has historically been thought that senescence may act as
a natural barrier to tumorigenesis. However, more recent evidence has demonstrated that chronic senescence
and SASP production can alternatively lead to systemic inflammation that sets the stage of tumor development
and subsequent progression and metastasis. Whether senescence or specific senescent cell types functionally
contribute to prostate cancer onset, progression, and immune suppression remains unknown.
To address this question, we have crossed GEMMs we have developed that recapitulate the early and late
stages of prostate tumorigenesis with p16-3MR mice that allow tracking and depletion of p16+ senescent cells.
Using these models and prostate cancer patient samples we observed that markers of cellular senescence
remain elevated during disease progression and can be found in multiple heterogenous cell types, and that
depletion of senescent cells can block tumor formation and reverse immune suppression. As such we
hypothesize that senescent cells promote prostate immune suppression and tumorigenesis and their targeting
can reactivate immune-mediated tumor control. In Aim 1, we will use multiplexed staining, single cell spatial
transcriptomics, and ex vivo functional analyzes to identify and phenotypically characterize distinct populations
of senescent cells during disease progression in prostate cancer GEMMs and patient samples. In Aim 2,
genetic and pharmacological tools will be used to assess the impact of senescent cell depletion (i.e. senolysis)
and SASP suppression on tumor progression. In Aim 3, we will evaluate whether senolytic therapy can reverse
prostate immune suppression and potentiate currently ineffective anti-PD-1 immune checkpoint blockade (ICB)
therapy to drive immune-mediated prostate cancer control in the preclinical setting. Collectively, these
approaches have the potential to not only advance our basic mechanistic understanding of how senescence-
mediated inflammation can foster tumorigenesis, but also guide the translational development of (a) prognostic
biomarkers of aggressive disease and (b) new therapeutic targets and strategies for treating prostate cancer.

Public health relevance
PROJECT NARRATIVE It is still unclear why some prostate cancers remain indolent for decades, yet others progress rapidly and fail to respond to standard-of-care hormone therapy. We and others have found that markers of cellular senescence, a stress pathway induced by oncogenic signaling that can impact tumor growth and immune activity, are present in mouse and human prostate cancer lesions. This proposal aims to address the functional contribution of senescence and specific senescent cell populations to prostate tumor onset and progression, immune suppression, and immunotherapy responses, and by doing so not only develop new senescence-related biomarkers prognostic of disease progression, but also novel immune-based targets and therapeutic strategies for treating prostate cancer.